RESPIRATORY DISORDERS OF SLEEP IN CHILDREN

Cardiorespiratory and neurophysiologic changes which occur during sleep in normal children and in children suffering from sleep-disordered cardio- respiratory function are being studied.